Energy-sensing Pathways, Healthy Aging and Longevity

7. Project Abstract The Kuakini Medical Center (Kuakini) Hawaii Healthspan Study will focus a multidisciplinary team of genetic, epidemiological, and geriatric scientists on the use of innovative approaches for secondary data analysis. We will use existing human data and specimens from the 45-year Kuakini Honolulu Heart Program /Honolulu Asia Aging Study, longitudinal studies of aging and chronic diseases in Japanese-American men. Our work will focus on functional characteristics of healthy aging over the lifespan (healthspan) and will attempt to identify genetic factors that help people survive to older ages in good health. While terms such as successful, healthy or effective aging describe a paradigm of aging with minimal chronic disease, the functional (physical and cognitive), characteristics of such aging are poorly understood and little is known about genetic or environmental predictors. In recent work we have 1) Operationalized phenotypes of healthy aging that use performance-based measures of function 2) Identified environmental predictors of healthy aging and longevity in a longitudinal study, 3) Found a gene (FOXO3A) with variants strongly associated with healthy aging and longevity; 4) Replicated the CETP gene association with longevity and extended the finding to healthy aging. For the current study, we propose to: 1) IDENTIFY additional genes associated with longevity using a two stage nested case-control study of candidate genes from energy sensing pathways and sequencing around areas of interest; 2) CONDUCT a prospective study of genetic predictors of survival and healthy survival; 3) CONDUCT a prospective study of genetic predictors of rate of change in major aging related traits. Discovery of biologic pathways that affect vulnerability to disease and disability could have a dramatic impact on our ability to achieve healthy old age by identifying biological targets for new therapies. Our study directly supports NIA's mission to improve the health and well-being of older Americans.

Public health relevance
Project Narrative The Kuakini Medical Center (Kuakini) Hawaii Healthspan Study will investigate how people's genes affect their ability to achieve healthy old age. This study focuses on understanding physical and cognitive function over the lifespan and identifies genetic and environmental factors that enable people to survive to exceptional ages in good health. Research on factors that lead to healthy aging may help us develop therapies that result in less age-related disease and disability and increase quality of life at older ages. __SpecificAimsTextDelimiter__ 5.5.2. SPECIFIC AIMS The "oldest-old" (ages 85+) is the most rapidly growing U.S. subpopulation [6]. Identifying strategies for remaining healthy, vigorous and disability-free at older ages has become a major priority as reflected by the Surgeon General's Proposed Health Objectives 2020 [7] and the NIA Strategic Plan [8]. While terms such as "successful" [9], "healthy" [10] or "effective" [11] aging describe a paradigm of aging with minimal chronic disease and disability, the clinical morbidity (major clinical disease) and functional (physical, cognitive, psychosocial) characteristics are poorly understood. This investigation will better quantify the clinical and functional characteristics of healthy aging over the lifespan and will identify biological and behavioral factors that enable people to extend their healthy years of life or "healthspan." This project will utilize existing human longitudinal data and specimens from the Honolulu Heart Program (HHP), a 45+ year follow-up study [12]. We propose to build upon previous work where we: 1) developed phenotypes [13,14]; 2) measured environmental predictors [14] and 3) found two genetic correlates of healthy aging and longevity [2,5]. Hypothesis: "Healthspan" is associated with more robust biological and behavioral traits that reflect: 1) increased physiological reserve; and 2) slower age-related loss of function through protective genetic factors linked to evolutionarily conserved energy-sensing pathways. This hypothesis is based on the following observations. First, lifespan is a quantitative outcome that can be measured in years. Healthy aging or "healthspan" is more difficult to measure but may be quantified more accurately by using performance-based measures of physical, cognitive and psychosocial function and well-documented medical and psychosocial history [13,15]. Second, there is retrospective evidence that functional health can exist over the lifespan based studies of very old humans [16-18]. A large proportion of centenarians appear to have delayed significant clinical disease and disability until late in life. Well- documented prospective data are required to substantiate and explore the etiology of this phenomenon. Third, evolutionarily conserved metabolic pathways related to insulin/IGF-1 signaling in model organisms (nematodes [19], fruit flies [20] and rodents [21]) are associated with a healthy aging phenotype and longevity; Fourth, recent studies of humans (including work from our institute) have found single nucleotide polymorphisms (SNPs) in this pathway that are associated with healthy aging and longevity [2,5,22-25]. Much of the previous research on long-lived humans and healthspan is self-reported and retrospective [10]. This work would benefit from further validation through longitudinal study utilizing objective, performance- based measures of function. A major challenge is that decades of follow-up of a very large and long-lived cohort are required. One of the few datasets in the world that meets these criteria is the Kuakini HHP, which has 45 years of follow-up of over 8,000 Japanese American men, including greater than 1,500 nonagenarians and centenarians. These men possess what may be the longest survival and highest functional capacity at older ages among all US male populations [26-28] and thus are more likely to cluster traits associated with healthy aging [2,5,14]. Based on these observations and our preliminary data, the Kuakini Hawaii Healthspan Study will focus a multidisciplinary team of scientists on the use of innovative approaches in a secondary data analytic study of healthy aging. We have the following specific aims: 1. IDENTIFY ADDITIONAL GENES ASSOCIATED WITH LONGEVITY USING A TWO STAGE NESTED CASE-CONTROL STUDY OF CANDIDATE GENES FROM ENERGY SENSING PATHWAYS AND SEQUENCING AROUND AREAS OF INTEREST. We have previously identified FOXO3A gene variants associated with healthy aging and longevity [2] using this approach. 2. PROSPECTIVE STUDY OF GENETIC PREDICTORS OF SURVIVAL AND HEALTHY SURVIVAL. Predictor variables are novel gene variants from energy sensing pathways discovered in Aim 1. Will use 2,104 subjects healthy at baseline and up to two decades of follow-up for a true incidence study of healthy aging. 3. PROSPECTIVE STUDY OF GENETIC PREDICTORS OF RATE OF CHANGE IN MAJOR AGING RELATED TRAITS. (e.g., traits include height, grip strength, walking ability, blood pressure, lung function, cognition). Predictor variables are novel gene variants from energy sensing pathways in Aim 1. Will use same subjects as Aim 2. 1